Computational Component

Core D will provide the informatics, computational biology, and statistical support for the analysis of antibody somatic genetics and the correlation of antibody genetics with affinity, neutralization capacity, and other correlates of protection. Core D personnel have developed state-of-the-art tools that permit such analyses to be conducted, and will apply these tools to the data generated by the investigators in the P01 research teams. Furthermore, Core D researchers will continue to develop methods as needed by the group as a whole.

Public health relevance
Affinity maturation is a key component of the immune response to vaccines. Antibodies become the first line of defense in post-vaccine exposure to the targeted pathogen through affinity maturation. Sophisticated mathematical analysis applied to technologically advanced data assays will enhance our understanding of this important process and greatly facilitate the design of greatly improved next-generation vaccines.